Causes and Population-genetic Consequences of Molecular Variation

Abstract
This project focuses on elucidating the mechanisms of evolution at the molecular and population-genetic levels
by integrating theoretical and experimental work in a wide phylogenetic framework. The molecular focus is on
cellular rates of error production in prokaryotic and eukaryotic species, in particular erroneous protein
production resulting from messenger RNA mistranslation. This work will test the drift-barrier hypothesis, which
postulates that the level of refinement that natural selection can achieve with any trait is limited by the power of
random drift but enhanced by the effective genome size and/or number of molecular transactions. Newly
developed methods in proteomics will yield rigorous estimates of the apparently high rates at which erroneous
amino acids are incorporated into proteins, complementing prior work at DNA and RNA levels.
The genetic mechanisms of evolution will be clarified by integrating population-genomic surveys of 1000s
of genotypic isolates of the model microcrustacean Daphnia pulex and related species with functional analyses
of key genes known to be involved phenotypic divergence. This work will reveal the relative magnitudes of drift,
mutation, and recombination in a collection of ~30 populations, far beyond that for any other species. Combined
with a long-term temporal survey, the results will enable a test of the hypothesis that variation at the level of gene
structure and genomic architecture is directly driven by the local population-genetic environment. The D. pulex
system has unique features for gaining insights into major unsolved mysteries in evolutionary genetics, including
the causes and consequences of the loss of meiotic recombination, the genetic mechanisms of sex determination,
and the coevolutionary constraints within and among mitochondrial and nuclear-encoded genes as determinants
of ribosome structure and bioenergetic capacity.
A third project develops evolutionary theory, which combined with the empirical observations, is
designed to clarify how phenotypic divergence emerges among isolated lineages. Special attention will be given
to the joint roles played by genetic drift and fluctuating selection in driving adaptive and nonadaptive patterns
of evolution, as well as to matters of molecular coevolution that form the basis of most intracellular features.
Because cellular integrity depends on the production of proper proteins, our work on translation fidelity
has broad significance for diverse human-health issues, including matters related to cellular toxicity and protein
aggregation. By integrating direct observations on the relative power of drift, mutation, recombination, and
fluctuating selection, the population-genomics work will yield insight into the factors driving the efficiencies and
mechanisms by which all species respond to natural selection. Elucidation of the molecular/cellular mechanisms
converting sexual reproduction to asexual propagation via unfertilized eggs and the separate mechanisms
preventing male production will open up possibilities of clonal propagation in diverse species as well as possible
strategies for pest control.

Public health relevance
Project Narrative This project is focused on the molecular-genetic mechanisms associated with the evolution of genetic variation, diversification of phenotypes, and the consequences for organismal fitness. The research will: 1) generate a comprehensive understanding of the rates at which cellular errors arise at the DNA, RNA, and protein levels across the Tree of Life and develop theory to explain the patterns; 2) further establish the Daphnia model system to help understand the evolutionary features of genes involved in key functions such as translation, bioenergetics, environmental sensing, and lifespan determination; and 3) develop theory to explain scaling patterns in the emerging field of evolutionary cell biology and the mechanisms by which cells evolve.